Overall: Eunice Kennedy Shriver Intellectual and Developmental Disabilities Research Center at Vanderbilt

Founded in 1965 as one of the original Intellectual and Developmental Disorders Research Centers
(IDDRC), the Vanderbilt Kennedy Center (VKC) IDDRC serves as the central nexus across Vanderbilt for
interdisciplinary research, communication, and training in intellectual and developmental disabilities (IDD). The
VKC IDDRC serves as a cross-institutional institute that brings together over 200 faculty from 38 departments
in 10 schools at Vanderbilt. The VKC’s mission to facilitate discoveries that inform best practices to improve the
lives of people with IDD and their families. This mission is met by leveraging our outstanding institutional
resources and support, partnering with disability communities, and capitalizing on synergistic interactions
across the VKC’s federally designated centers: the VKC IDDRC, a University Center of Excellence in
Developmental Disabilities and a Leadership Education in Neurodevelopmental Disabilities program. The
IDDRC as the centerpiece of the VKC is the foundational organizing structure that creates a “Center culture”
wherein research and discovery permeates the VKC’s broader training and service activities, thus enhancing
the translational research goals of the IDDRC. Demonstrable IDDRC success includes 976 investigator-
authored publications (2015-2020) and robust NIH funding to Vanderbilt to support IDD-related research
($52.6M in FY20). Harnessing and leveraging this cross-institutional strength to focus on unique challenges in
IDD, the overarching goal of the next phase of the IDDRC is to develop precision care for IDD by
providing infrastructure and scientific leadership to enable rapid translation of basic discoveries into
high-impact IDD interventions and treatments. Three global Aims guide the IDDRC’s work. Aim 1 provides
core services to enable and disseminate impactful research on individualizing treatments based upon the
causes, mechanisms, and contributing co-morbid sequelae of IDD; Aim 2 focuses on incorporating innovative
methods and approaches to enhance multidisciplinary IDD research; and Aim 3 proposes to conduct a
signature research project to improve the precision use of antipsychotic medication in people with autism.
Across these Aims and five Cores supported by the IDDRC (Administrative, Clinical Translational, Translational
Neuroscience, Behavioral Phenotyping, and Data Sciences), three themes permeate our work: (1) recruitment
of highly-skilled researchers not currently conducting IDD research; (2) enhancing participation of people with
IDD into research studies that currently do not involve IDD; and (3) incorporation of novel scientific approaches
and methods. Our IDDRC is ideally posed to enable rapid discovery of precision care approaches by
supporting 50 investigators leading 70 research projects (15 from NICHD), and, as highlighted by the Signature
Research Project, to promote and implement generative, novel, and impactful research directions, thus
meeting the NICHD’s vision of applying newly evolved technologies and approaches to rapidly accelerate the
prevention and/or amelioration of IDDs.

Public health relevance
As a group, intellectual and developmental disabilities, including Down syndrome and autism spectrum disorder, have dramatic effects on affected people’s and their caregiver’s lives. Unfortunately, there remains a lack of understanding about what causes these disabilities and, critically, how to treat them with targeted therapies. The Vanderbilt Kennedy Center’s Intellectual and Developmental Disabilities Research Center serves as the hub for Vanderbilt’s research efforts focusing on improving the lives of people with intellectual and developmental disabilities by understanding the causes of these disorders and developing and testing therapies tailored to each individual’s precise needs.